Improving Safety of Cardiovascular Implantable Electronic Devices in Veterans

Background: This proposal is intended to support the career development of Sanket Dhruva, MD, MHS, a
Staff Cardiologist at the San Francisco VA and Assistant Professor of Medicine at the University of California,
San Francisco into an independent VA health services researcher with the training and experience necessary
to conduct innovative research and develop interventions that improve safety of Veterans with cardiovascular
implantable electronic devices (CIEDs: pacemakers and implantable cardioverter defibrillators [ICDs]). Even
though more than 10% of the 55,000 Veterans followed by VA have suffered CIED-related complications, there
has not been any systematic evaluation to identify failed CIED leads using VA’s data systems.
Significance/Impact: This research will close Dr. Dhruva’s knowledge gaps in biostatistics, data science, and
qualitative methods, enabling him to generate actionable, high-quality evidence to inform VA cardiac
electrophysiologists to implant the safest devices in Veterans. This research will also enable him to identify
CIED leads that have already been implanted in Veterans but are at risk for failure, thereby informing
strategies to avoid clinical sequelae of failure (such as inappropriate shocks and death) for individual Veterans.
This proposal is directly aligned with operational priorities set forth in VHA Directive 1189 (published in January
2020) to “monitor the safety of CIEDs,” HSR&D Priorities of a Learning Healthcare System and improving
Veteran Quality of Care and Safety, and supports VHA’s priority of becoming a High-Reliability Organization.
Innovation: This research is innovative through its application of advanced statistical methods to leverage a
comprehensive, longitudinal database of Veterans with CIEDs, the VA National Cardiac Device Surveillance
Program (NCDSP), including temporally dense CIED-generated data, to address the large-scale, complex
problem of identifying CIED lead failure. Additionally, this research provides information about the unexplored
question of physician selection of manufacturer and model of device to implant and the role of safety data.
Specific Aims: Aim 1: To compare risk-adjusted failure rates of different cardiovascular implantable
electronic device (CIED) lead models among Veterans.
H1: We will detect one or more CIED lead models with statistically and clinically significantly higher failure
rates when compared to other leads of the same type (e.g. ICD lead when compared to all other ICD leads).
Aim 2: To develop risk prediction models of all-cause CIED lead failure among Veterans by applying
supervised machine learning methods to repeated measures from CIED remote monitoring data.
H2: Risk prediction models will detect lead failure with high discrimination (area under the curve [AUC] ≥0.85)
and adequate calibration at 3 months and 12 months post-assessment.
Aim 3: To conduct a pilot study to determine the effect of an academic detailing and audit and
feedback intervention on the specific CIED lead models implanted in Veterans.
H3: Post-intervention, Veterans will more often be implanted with lead models associated with the lowest
failure rates.
Methodology: Aim 1 will use sequential propensity score-adjusted simulated prospective survival analyses
applied to a dataset of the NCDSP linked to VA’s Corporate Data Warehouse and Medicare data. Aim 2 will
apply two supervised machine learning techniques, elastic net and random forests, to quarterly patient-
generated data from CIEDs to create prediction models. Aim 3 will include qualitative interviews of cardiac
electrophysiologists about device selection and the development, implementation, and evaluation of an
academic detailing and audit and feedback intervention for cardiac electrophysiologists in 3 VISNs.
Implementation: This research will enable Dr. Dhruva to become an independent VA HSR&D investigator who
conducts research to improve outcomes for Veterans with CIEDs and those who will receive one in the future.

Public health relevance
More than 55,000 Veterans are living with a cardiovascular implantable electronic device (CIED): pacemaker or implantable cardioverter-defibrillator, which include 1 to 3 implanted cardiac leads. Unfortunately, hundreds of thousands of CIED leads have been recalled because of high failure risk. These recalls have occurred too late, spurred only by adverse event reports after patients suffered consequences such as inappropriate shocks and even death. There is no surveillance system to identify failing CIED leads. Through this research, population-level analyses will be conducted to identify CIED lead models with the lowest failure risk; these data will inform an intervention to support VA physicians in implanting the safest leads in Veterans. This research will also create a system to predict which lead(s) currently implanted in individual Veterans are at risk for early failure, thereby informing strategies to mitigate risk. Overall, this research will improve safety by reducing the number of Veterans who suffer CIED lead failure, thereby helping Veterans live longer with better quality of life.